Randomized-controlled trial of virtual reality for chronic low back pain to improve patient-reported outcomes and physical activity: Understanding Patient Predictors of Response

PROJECT SUMMARY Although digital health technologies are now widely available for both therapeutic and monitoring applications, there are wide variations in patient knowledge, attitudes, beliefs, and preferences regarding uptake and effectiveness of digital health interventions. In addition, there are sociodemographic variations in willingness to engage in digital health studies, both for chronic pain and other common disorders. However, there have been few efforts to systematically examine patient-level predictors of digital health uptake and benefit among diverse patients with chronic pain. In this pilot study, we will employ mixed methods to examine variations in engagement and benefit among diverse participants in a large NIH-sponsored trial examining benefits of virtual reality (VR) for chronic lower back pain (cLBP).

Public health relevance
PROJECT NARRATIVE Although digital health technologies are now widely available for both therapeutic and monitoring applications, there are wide variations in patient knowledge, attitudes, beliefs, and preferences regarding uptake and effectiveness of digital health interventions. In this pilot study, we will employ mixed methods to examine variations in engagement and benefit among diverse participants in a large NIH-sponsored trial examining benefits of virtual reality (VR) for chronic lower back pain (cLBP).